Expectations and Outcomes of Healthcare Transition in Adolescents and Young Adults with Cystic Fibrosis

PROJECT SUMMARY/ ABSTRACT. Adolescents and young adults (AYAs) with cystic fibrosis (CF) are at risk
for gaps in continuity of care and poor clinical outcomes during the transition from pediatric to adult outpatient
care. Healthcare transition is the planned and purposeful movement from pediatric to adult care. Across CF
care centers, transition preparation practices are not standardized and poor outcomes such as gaps in
recommended care and subsequent clinical deterioration still occur. This lack of standardization is in part due
to insufficient evaluation of the outcomes of current transition preparation programs. Additionally, there is a gap
in the qualitative literature on AYA and parent perspectives of healthcare transition in the United States. Filling
these gaps would help to promote the creation of standardized, evidence based and AYA and family centered
transition programs that would ultimately improve healthcare transition outcomes for AYAs with CF. The aims
of this study are to evaluate the post-transition outcomes of a current transition preparation program for AYAs
with CF and to explore adolescents with CF and parent expectations and perceptions of healthcare transition.
This study aligns with the National Institute of Nursing Research priority area of self-management. Additionally,
this study aligns with the Healthy People 2020 goal to “Improve the healthy development, health, safety, and
well-being of adolescents and young adults”. Ultimately this study will help to promote successful, independent
illness self-management and improve the transition preparation process for AYAs with CF. The expanded
socioecological model for adolescent and young adult readiness for transition will be used to guide this mixed-
methods study. This framework provides a holistic view of healthcare transition by addressing the multiple
factors that influence transition readiness and post-transition outcomes. For the quantitative aim of this study
we will examine biomedical outcomes (lung function and nutrition status) and behavioral outcomes (continuity
of recommended outpatient care and engagement in care) comparing AYAs who participated in a structured
transition preparation program compared to those who did not at a large, urban, academic medical center. We
will use data from the Cystic Fibrosis Foundation Patient Registry and CF R.I.S.E. transition program
participation records to achieve this aim. The qualitative aim will be achieved though semi-structured interviews
with 15 adolescents with CF/parent dyads. This study will be supported by a strong mentorship team and will
benefit from the many resources available at Columbia University School of Nursing. An established
collaborative relationship with 2 CF Care Centers (1 adult, 1 pediatric) will facilitate recruitment and data
access. Results of this study will add to the literature on healthcare transition and promote the development of
AYA and family centered transition preparation programs to improve transition outcomes for AYAs with CF.

Public health relevance
PROJECT NARRATIVE The median life expectancy for people with cystic fibrosis (CF) is currently 47.4 years which necessitates that young people with CF must transition from pediatric to adult care. If young people with CF are not adequately prepared for the transition to adult care and the associated increase in self-management responsibility, they are at risk of poor outcomes such gaps in continuity of recommended care and clinical detioration. The proposed study will support the development of standardized, youth and family centered transition preparation programs by evaluating the post-transition outcomes of the current transition program at one urban center as well as exploring youth and parent expectations and perspectives of the healthcare transition process.